Suubi+Adherence4Youth: Optimizing the Suubi Intervention for Adherence to HIV Treatment for Youth Living with HIV in Uganda

PROJECT ABSTRACT
The number of adolescents living with HIV (ALHIV) in Uganda is over 170,000 and growing. Ugandan ALHIV
are a priority due to social and structural inequities that make them highly vulnerable to HIV infection and sub-
optimal access and adherence to antiretroviral therapy (ART). Less than 50% of ALHIV in Uganda are ART-
adherent, leading to low rates of viral suppression and high attrition from HIV care. In response to calls for
expanding differentiated care approaches for ALHIV and new forms of combination HIV interventions, we seek
to intervene on social and structural inequities that exacerbate the risk for viral load non-suppression. Addressing
these hardships can improve ALHIV’s livelihoods and give them the knowledge and resources to sustainably
manage HIV. We have shown the effectiveness of Suubi (Hope) in four NIH-funded RCTs in Uganda. Suubi is
an evidence-based and theory-informed combination intervention with four components: 1) Financial Literacy
Training; 2) Incentivized Matched Youth Savings Accounts with income-generating activities; 3) a manualized
intervention for ART adherence and stigma reduction; and 4) Engagement with HIV treatment-experienced role
models who share lived experiences of HIV. Suubi has shown robust effects on viral suppression and ART
adherence, mental health and psychosocial outcomes, and family financial stability. Yet, it is unknown if each
component in Suubi had a positive effect, how the components interacted, or if fewer components could have
produced equivalent effects. Hence, we propose a factorial experiment to unpack and optimize Suubi to enhance
scale up in health systems using the multi-phase optimization strategy (MOST). We define our “optimization
objective” as the most cost-effective combination of intervention components considering three real-world
constraints: 1) efficiency, 2) affordability, and 3) scalability. We then evaluate the intervention component effect
sizes and balance these data against real-world information and costing data to empirically arrive at optimization.
The study aims are: Aim 1. Conduct a factorial experiment (optimization trial) to test the main effects of each of
the four Suubi intervention components and combinations of components (interactions) on viral suppression
(primary outcome); Aim 2. Test mediators and explore moderators that explain and modify the relationship
between each of the four Suubi intervention component and viral suppression; and Aim 3. Compare the cost and
cost-effectiveness of each of the four Suubi intervention components and every combination of components. We
will use a 24 factorial experiment with 16 conditions representing all combinations of the 4 components. Health
clinics (N=48) will be randomized to 16 conditions (12 ALHIV per clinic), yielding main effects and interaction
effects for the 4 components on sustained viral suppression (defined as an undetectable viral load at 12-, 24-
and 36-month follow-up assessments). An optimized intervention built within real-world constraints in SSA for a
high-priority group is an innovative and promising way to advance intervention science for HIV care globally.

Public health relevance
PROJECT NARRATIVE The number of adolescents living with HIV (ALHIV) in Uganda is over 170,000 and growing, yet less than 50% of ALHIV in Uganda are ART-adherent, leading to low rates of viral suppression due to social and structural inequities. Informed by the multi-phase optimization strategy (MOST), we propose to conduct a factorial experiment (optimization trial) to identify the most cost-effective combination of four-intervention components for viral suppression and ART adherence, as well as mental health and several psychosocial outcomes among ALHIV in Uganda. The proposal will unpack a multi-component combination intervention named Suubi that uses economic empowerment and psychosocial intervention components to address social and structural inequities, with the goal of optimizing the Suubi intervention to enhance scale up in health systems and advance intervention science for HIV care globally.